Non-resonance Electron Spin Imaging

Project Summary /Abstract
Traditional magnetic resonance imaging methods, such as MRI, use radiofrequency (RF) waves to manipulate
the spin, a quantum-mechanical property of subatomic particles. These particles include various types of nuclei
and the electron. Constant magnetic fields are used in experiments, the strength of which must match the RF to
observe resonance phenomena. The spins are very sensitive reporters of their local molecular environment.
They can report the concentration, dynamics, and interactions of the surrounding molecules. However, the
current resonance approach has its limitations that stem from the use of radio waves. When RF propagates
through the sample, only an infinitesimally small amount of power contributes to the observable signals. Most of
the energy is absorbed by the imaged object. RF energy dissipates as heat. Associated with this very inefficient
use of power are multiple problems such as sample heating, limited penetration depth, power saturation of signal
amplifiers, spin system saturation (distorts data), and increased noise. These problems are especially critical for
electron-based paramagnetic resonance imaging. An alternative to traditional EPR, RF-free non-resonance
electron spin imaging (NESI) method is proposed. This technology overcomes the limitations associated with
the use of RF power. The key concept behind NESI is relatively simple. In the traditional methods, RF is used to
rotate spin magnetization relative to the constant magnetic field. In NESI, the magnetic field is rotated with
respect to the magnetization vector. Both experiments measure the precession of the magnetization vector
around the constant magnetic field. Several innovative mathematical and engineering solutions are proposed to
transform the described above concept into a fully functional imaging system. The NESI instrument will be built
and rigorously tested using a wide range of samples (phantoms) with pre-determined geometry. A several-fold
increase in sensitivity is expected compared to the standard EPR imaging method when traditional classical
detection methods are used. Recent developments of quantum sensing promise unprecedented sensitivity for
the detection of electron spin signals. These novel technologies are incompatible with the traditional EPR.
Several standard types of spin probes will be used to image oxygen partial pressure (pO2) and acidity (pH)
distribution in these phantoms. In future studies, NESI will be used in pre-clinical and clinical studies. Imaging of
chemical microenvironment in bio-printed tissue and organ models is another important application of this
technology.

Public health relevance
PROJECT NARRATIVE The traditional magnetic resonance methods use radiofrequency radiation to observe images. A non-resonance radiation-free approach is proposed that will solve power heating, noise, and other problems associated with these standard methods. A novel method will be developed to image the chemical microenvironment of tissues, tumors, and bio-engineered models to study cancer and other types of human illnesses.